Determining How CACNA1C Variants Cause Interneuron Pathophysiology

PROJECT SUMMARY: Neurodevelopmental disorders impact up to 24% of children. The pathophysiology of
most neurodevelopmental disorders is poorly understood preventing therapeutics; however, calcium
dysregulation and interneuron dysfunction are implicated in many disorders. CACNA1C encodes a CaV1.2 L-
type calcium channel subunit. Variants in CACNA1C cause a spectrum of neuropsychiatric symptoms. A
CACNA1C gain of channel function variant impairs interneuron migration and cortical development in human
induced pluripotent stem cell (hiPSC) derived neural organoid and assembloid models. We do not know the
neuronal pathophysiology of CACNA1C loss of function or channel-neutral variants. Investigating the interneuron
phenotypes of clinically severe CACNA1C variants will elucidate downstream pathways regulating interneuron
pathology that contribute to a cortical network phenotype, potentially indicating treatments. The applicant, Dr.
Rebecca Levy, proposes to employ gene editing to develop novel hiPSC lines and neural assembloids, then
leverage calcium indicators, live imaging, and RNA sequencing analysis to determine how CACNA1C variants
impact mechanisms directing interneuron migration. In Aim 1, Dr. Levy will learn CRISPR/Cas9 gene editing to
generate 3 novel hiPS cell lines of CACNA1C including variants that cause loss of function and no change in
calcium flux in non-neuronal cells. She will hone her skills in neural organoid culture to derive subpallial organoids
and quantitate calcium activity with Fura-2 and interneuron-specific GCaMP calcium indicators, as well as CaV1.2
channel agonists and antagonists to rescue phenotypes. In Aim 2, Dr. Levy will develop cortical-subpallial
assembloids and use live imaging to measure interneuron migration saltation length and frequency, then how
cortical network activity is affected within assembloids. In Aim 3, Dr. Levy will confirm mechanisms via Western
blot, pharmacologic rescue, and single cell RNA sequencing analysis. This will also generate new hypotheses
about pathways affected in both gain and loss of function variants for future grants. Dr. Levy is a neurogeneticist
with experience in mouse and neural organoid models. Her career development plan addresses training gaps in
gene editing, neural assembloid culture, advanced imaging techniques, expression analysis, and scientific
communication. Her mentor, Dr. Sergiu Pasca, is a leader in neural organoid culture techniques. Her advisory
mentors are Dr. Porteus (gene editing), Dr. Hall (Cacna1c rodent models), Dr. Huguenard (systems
neuroscience), and Dr. Bernstein (rare disease geneticist). Stanford provides a rich environment including core
facilities, seminars, courses, and collaborations. With this dedicated mentorship team, outstanding institutional
environment, and thoughtful training and career development plans, Dr. Levy has the resources and support to
launch her independent physician-scientist career. This proposal will discover interneuron pathophysiology
caused by CACNA1C variants with variable impact on channel function, identifying core mechanisms that could
become therapeutic targets.

Public health relevance
Project Narrative Pathogenic variants in CACNA1C, encoding a subunit of the essential neuronal L-type calcium channel CaV1.2, cause a spectrum of cardiac and neuropsychiatric disorders including epilepsy, developmental delay/intellectual disability, and autism spectrum disorder. The pathophysiology of CACNA1C related disorders and thus treatment approaches are unknown, particularly for loss of function variants. I will develop and analyze novel CACNA1C variants in human-derived neural organoids and assembloids to determine how differences in calcium influx impact interneuron migration and thus neurodevelopment to advance our mechanistic understanding of this disease and potential therapeutic approaches.